Thermodynamically Calibrated RNA Simulations to Decode Mechanisms of RNA MolecularRecognition

ABSTRACT
This MIRA proposal details the continued development of improved, thermodynamically
accurate computer models for simulating RNA structures, folding pathways, and molecular
recognition at atomistic resolution. These models differ from existing models for RNA in that
they are calibrated to reproduce solution thermodynamic data on the physical behavior of
nucleotides and nucleosides, an approach that is readily extended to include the effects of
unnatural RNAs and RNA-ligand interactions. This technology is particularly important as many
biomedically important RNAs are not amenable to traditional structural biology techniques,
which makes it difficult to establish basic structure-function relationships that must be
understood before potential therapeutic interventions could be designed.
This proposal builds on several recent successes including using SHAPE restrained
simulations to explore the folding pathway of a co-transcriptionally folded RNA, reveal the
switching mechanism of riboswitches, and predict the structure of a novel RNA aptamers that
only fold upon binding their ligands. Building on these recent results, a comprehensive
research program is proposed in three major parts. First, we will de-novo fold an entire 76 nt
tRNA molecule, including all native modification and divalent ions. This will be made possible
due to our extensive experience in simulating modified nucleotides, recent progress in
simulating Mg-RNA interactions and our multi-simulation restrained folding technology.
Secondly, we will expand our ability to simulate induced-fit binding of a range of small
molecule ligands to their RNA aptamers, enabling us to predict where modifications can be
introduced to improve target specificity. Finally, we will develop improved ways to simulate
protein-RNA complexes, using the modular PPR proteins as a calibration, and miRNA/mRNA
complexes annealed within the hAGO2 protein as a model system.

Public health relevance
PROJECT NARRATIVE This project proposes a new method for using computer simulations to determine the structure and function of RNA in 3D, atomic detail, for which no experimental structures are available. If successful, these studies will enable the rational engineering and design of RNA-based biosensing/nanotechnology applications as well as help solve challenging puzzles in RNA structural biology to understand how RNA molecules are able to recognize a diverse array of biological targets.